New Kv7 modulators to stop sensitized overexcitation of neurons

Summary
This R21 aims to create a robust empirical basis for the development of pain therapies by targeting the
regulation of neuronal Kv7 channels. In the US, approximately 50 million adults suffer from chronic pain, and
17 million peoples experience high-impact chronic pain. Neuronal Kv7 channels are a class of low-voltage
gated potassium channels that generate the M-currents, which counteract generating action potentials at or
near the resting potential. M-current suppression induced by some inflammatory mediators and
neurotransmitters transiently increases neuronal excitability and exacerbates pain. Thus, preventing M-current
suppression may provide a potent novel approach to mitigate sensitized pain. In fact, our prior study using
mutant Kv7.2 knock-in mice, which showed reduced M-current suppression, demonstrated a reduction in
inflammatory pain. Based on this insight, we developed a novel in silico screening process identifying
compounds that enhance stability of binding between Kv7 channels and the essential co-factor phosphatidyl-
inositol 4,5-bisphosphate (PIP2), which plays a critical role for M-current suppression. Aligned with this idea,
we have identified that the endogenous hormone DHEAS attenuates M-current suppression and mitigates
inflammatory pain. In addition, our very recent preliminary study has indicated some Kv7 modulators of this
class caused a hyperpolarizing shift of activation voltage in addition to attenuation of receptor-induced Kv7.2
current suppression. This R21 investigates the overall hypothesis that a new type of Kv7 channel modifiers,
which stabilizes the Kv7-PIP2 conformation, can effectively alleviate pain. We will test our hypothesis by
two cohesive aims. Aim 1-1 will utilize a novel screening process to identify potent compounds for this class of
Kv7 modifiers. Aim 1-2 will functionally verify candidate compounds by electrophysiological experiments for
attenuation of Kv7/M-current suppression and change in activation voltage. Aim1-3 focuses on identifying
crucial interactions that mediate the pharmacological effects by combining mutation analysis and
computational simulation. Aim 2 will evaluate the behavioral impacts of new Kv7 modulators identified in Aim 1
on mice, including sedation and pain responses. This R21 is entirely innovative because no drugs have been
developed to this drug binding site in the Kv7 channel. This mechanism of action will overcome the limitation of
existing Kv7 channel openers. We believe that this R21 is important both biologically and clinically because
data obtained will not only establish the foundation for a novel class of Kv7 channel modifiers but also provide
insights into their therapeutic potentials for chronic pain.

Public health relevance
Project Narrative Pain is the major public health challenge. This proposed R21 research will establish foundation of a new class of Kv7 channel modulators that mitigate pain. Outcomes from this novel study will provide a new non-opioid pain therapy.